THE HYPOPITUITARY CONTROL AND COMPLICATIONS STUDY

The primary goal of this study is to document long-term safety outcomes in somatotropin-deficient adults who are given somatotropin replacement therapy as compared with similar patients who elect not to be treated with somatotropin replacement therapy. Secondary goals of the study are as follows: To establish specific algorithms for safe and effective somatotropin dosage in adults. To evaluate the effect of somatotropin replacement therapy in conjunction with other hormonal therapies.